Breaching CNS barriers: Deciphering the spatiotemporal regulation of immune cell surveillance following blast TBI

Background: Dr. Krista DiSano currently serves as a Research Health Scientist at the White River
Junction VA Healthcare System (WRJ-VAHS). She is an active member of the VA and Dartmouth scientific
community, including the WRJ Translational Neuroscience Research Group directed by her primary mentor,
Dr. Paul Holtzheimer. Since joining this group, her research has focused on elucidating the mechanisms
regulating inflammation following shockwave-induced blast traumatic brain injury (bTBI). Military personnel are
particularly vulnerable to bTBI, which is considered a signature injury of recent wars. Common complications
following blast exposure include chronic neuropsychiatric impairments, including cognitive deficits and mood
disorders, which significantly affect quality of life. The underlying biological processes responsible for these
outcomes have not been fully characterized, but putative mechanisms include neuroinflammation. It has been
suggested that chronic neuroinflammation may contribute to neuropsychiatric impairments following blast
exposure, including anxiety and depression. Ongoing work by our laboratory and others is centered on
evaluating the utility of immunomodulation to improve outcomes. We posit that defining mechanisms
regulating immune cell infiltration into the CNS following bTBI will expand the implementation of
immunomodulation interventions for blast injury and guide personalized treatment. The current study
aims to begin to address these gaps in our knowledge by defining: 1) How immune cells enter the CNS
following bTBI; 2) Whether immune cell spatial location in the CNS influences post-injury outcomes; and 3) The
origin of immune cells recruited to the CNS following bTBI.
Dr. DiSano’s long-term goals are to identify factors supporting non-resolving neuroinflammation,
elucidate immune cell function after injury, and screen immunomodulatory therapeutics that may improve
outcomes. Her ongoing studies employ a pre-clinical, rodent model of bTBI to explore the complex
inflammatory processes following bTBI that cannot be addressed in clinical settings. The proposed project is
an extension of her VISN1 CDA-1 that focused on 1) evaluating how different cells of the immune system
respond to brain injury, and 2) identifying structural changes that promote cell entry into the CNS (e.g., blood-
brain barrier disturbances). As part of this work, she demonstrated that reducing immune cell entry into the
CNS via immunomodulation reduced chronic neuroinflammation, including microglial activation. These and
other preliminary findings guided the current project goals.
Current Proposal: Dr. DiSano’s mentored training and research will utilize several novel methodologies
to investigate how immune cell trafficking, spatial location, and origin impacts the CNS microenvironment and
behavioral consequences. The overall hypothesis postulates that following blast injury, the CNS responds by
creating a niche for immune cell entry into diverse subcompartments (e.g., parenchyma, meninges,
perivascular spaces) and immune cell persistence in these spaces influences tissue injury/repair and
behavioral outcomes. Dr. DiSano will leverage several immunomodulatory agents to investigate this
hypothesis. It is anticipated that this work will provide valuable insight to guide precision immunotherapy to
improve recovery following bTBI.
Relevance: The high prevalence of bTBI in service members warrants effective interventions.
Moreover, the debilitating cognitive and psychiatric complications often associated with bTBI requires the
development of novel treatment that targets underlying mechanisms, including neuroinflammation. The
proposed training and research activities will investigate neuroinflammatory processes after blast exposure and
will ultimately support Dr. DiSano’s long-term career goal to develop and implement efficacious
immunomodulatory treatments to meet this urgent need.

Public health relevance
Shockwave-induced blast traumatic brain injury (bTBI) is a signature injury of recent wars. Blast exposure can cause neuropsychiatric impairment that poses significant effects on quality of life, but effective treatment is limited, especially for chronic injuries. The discovery of novel therapies has been hindered by our incomplete understanding of the mechanisms underlying bTBI outcomes. Neuroinflammation is a major component of the injury cascade that may contribute to comorbid conditions, including cognitive deficits, depression, anxiety, and PTSD. The current application aims to explore how neuroinflammatory processes after injury influence recovery from blast exposure. Using a rodent model of bTBI, we will investigate the extent to which immune cell entry into the central nervous system after blast exposure modulates tissue injury and neurobehavioral outcomes. We aim to use the study findings to identify novel immunomodulatory therapies that effectively attenuate secondary injury cascades and improve recovery after bTBI.